Experimental Theoretical Studies of Cochlear Mechanisms

Project Summary
Based on its strategic location, the tectorial membrane (TM) has long been thought to play an essential role in
hearing, but the important cochlear mechanisms remain unclear. We propose research to improve our understanding
of the functional role of the TM in determining (1) the remarkable properties of normal hearing — including its
exquisite sensitivity and frequency selectivity — as well as (2) the hearing loss associated with genetic mutations
of the TM and other cochlear pathologies. Conventional models of cochlear mechanics represent the TM as a
viscoelastic solid, and while the importance of both viscosity and elasticity is well established, these models do not
account for the central role of water in this tissue. The TM is a gel: 97% water contained in a macromolecular matrix
of proteins and sugar groups. Recent studies show that sound-induced motions of water through this macromolecular
matrix plays a critical functional role in determining the timing of mechanical responses – and this timing is central
to determining the frequency selectivity that is a hallmark of mammalian hearing.
The proposed research will measure and characterize the important consequences of the gelatinous nature of the
TM, i.e., its poroelastic properties. This work is organized in two related aims. The ﬁrst investigates mechanical
consequences of poroelasticity. We have developed a technique based on atomic force microscopy to measure
mechanical properties of the TM at the level of single hair bundles. We will apply this technique to characterize
poroelasticity in TMs from normal-hearing rodents, as well as mice with genetic disorders of hearing. Our second
aim focuses on the role of ions (especially calcium) that are dissolved in the liquid phase of the TM. The TM has
been shown to concentrate calcium at levels well in excess of those in the surrounding endolymph. Changes in ionic
concentrations have been shown to alter the electro-mechanical properties of the TM, and will thereby also aﬀect
the closely apposed hair bundles of hair cells. The local concentration of calcium is known to aﬀect not only
the sound-induced receptor potentials of hair cells, but also adaptation processes that are necessary to maintain the
remarkable sensitivity of hearing.
Results from these studies will increase our understanding of the cochlear mechanisms that underlie both normal and
impaired hearing. This knowledge has important practical applications for the delineation of inner-ear disorders (and
concomitant suggestions for treatment) and for the design of speech-processing devices such as cochlear implants,
hearing aids, and speech-recognition systems.

Public health relevance
Project Narrative Our ability to communicate with each other and to navigate through acoustically rich environments depends on the detection and exquisite analysis of sounds by the inner ear. Numerous genetic studies have shown that the tectorial membrane plays a key role in shaping this analysis, but the important mechanisms are not well understood. The proposed research to clarify these underlying mechanisms will improve our understanding of both normal and impaired hearing, and will be important for the design of speech-processing devices such as cochlear implants, hearing aids, and speech-communication and speech-recognition systems.